Research Pharmacy

ABSTRACT
The Research Pharmacy (RP) Core provides a full service facility that prepares agents developed by
MSK researchers to be used as investigational drugs in preclinical or clinical studies. The Core comprises
three principal groups: the Pharmaceutical Product Facility (PPF) for drug formulation/stability and
preparation; the Clinical Grade Production (CGP) Facility for bulk product manufacturing, purification, and
vialing; and the Pharmacy Investigational Drug Service (PIDS), which provides a service to develop,
procure, prepare, and validate the preparation, packaging, and distribution of investigational drugs for clinical
use. The Core services include, but are not limited to, formulation, analysis, and evaluation of drug
release rates; prediction of interactions; and determinations of compatibility and physical stability of
medications. Owing to the infrastructure of the Core, MSK has been able to bring into early phase clinical
trials multiple distinct types of pharmacologic agents, including traditional small molecules,
radiopharmaceuticals, and vaccines.